A Novel Adipocyte Population Arises From Bone Marrow Progenitor Cells

DESCRIPTION (provided by applicant): Two thirds of Americans are overweight or obese. Excess body fat, particularly in the abdomen, has been linked to cardiovascular disease, type 2 diabetes, certain forms of cancer and other medical conditions. Strategies to prevent weight gain or its harmul effects on health have had limited success. This project will investigate how certain types of fat-toring cells (adipocytes) are produced in abdominal fat. The results may identify new targets for therapie to prevent weight gain and fat-related chronic disease. Over the last 7 years we have identified a population of adipocytes that are produced from stem cells in the bone marrow. These stem cells leae the marrow and travel to fat tissue where they become new adipocytes. These bone marrow-derived adipocytes accumulate preferentially in abdominal fat in female animals, and exhibit potentially hamful characteristics. This project is designed to determine why these cells are produced in abdominal fa, and if their production is more rapid than other types of fat-storing cells. The first aim will tes whether the inflammatory protein, monocyte inhibitory protein-1a (MIP-1a), promotes the recruitment of stem cells from the bone marrow to fat and the subsequent generation of bone marrow-derived adipocyte in abdominal fat. This will be accomplished by following labeled marrow progenitors to fat tissue in mce in which MIP-1a has been genetically erased. Aim 2 will test whether the ovarian hormones, estrogen an progesterone, are also involved in bone marrowadipocyte production and account for the preferential accumulation of these fat cells in female subjects. Finally, Aim 3 will use a novel labeling technoogy to measure the rate at which bone marrow-derived adipocytes and other fat-storing cells are produced i fat in different body locations. Completion of these studies will provide a comprehensive picture o the factors and processes that control bone marrow-derived adipocyte production. The results are likelyto highlight new targets for controlling the generation of these fat cells and thereby mitigate their armful effects on health. The results may also ex- plain why fat is stored differently between men and womn, and why fat storage in women changes after menopause. We predict that these experiments will furthe underscore the importance of stem cells and progenitor cells in the development of fat in differentbody locations and its differential impact on health.

Public health relevance
PUBLIC HEALTH RELEVANCE: Obesity is a major medical problem for which there are few effective therapies. This project will investigate why certain types of fat cells with potentially harmful characteristics are produced in specific body locations and in greater numbers in female than male subjects. Successful completion of these studies will identify new targets for controlling the prodction of harmful fat-storing cells and prevent fat-related chronic disease.